Biochemical Mechanism of HIV DNA Integration

HIV-1 remains a significant health problem. In 2022, 1.3 million people became infected globally, and 0.63
million people died from AIDS. 39 million people currently live with HIV. We still lack effective vaccine and
cure strategies. Antiretroviral inhibitors, which mainly target HIV-1 enzyme activities, have however altered
the course of the HIV/AIDS pandemic. Drug cocktails composed of two nucleoside reverse transcriptase
inhibitors and a second-generation integrase strand transfer inhibitor are commonly prescribed for drug-naïve
patients as well as individuals failing non-integrase inhibitor containing regimens. Integrase is the viral
enzyme responsible for integrating the viral reverse transcript into a cellular chromosome, which most often
occurs in concert with the chromatin-binding host protein lens epithelium-derived growth factor (LEDGF)/p75.
The binding of integrase to LEDGF/p75 targets integration to the mid-regions of active genes to enhance
subsequent transcription and HIV-1 pathogenesis. This grant over its lifetime has contributed seminal results
to the biochemical mechanism of HIV DNA integration, including the co-discovery of LEDGF/p75 as an
integrase binding protein, as well as the determination of the part of LEDGF/p75 that binds integrase and 3-
dimensional (3d) structure determinations of the LEDGF/p75 integrase binding domain (IBD) and IBD-
integrase complexes. Such results set the stage for the discovery of allosteric integrase inhibitors (ALLINIs),
which compete for LEDGF/p75 binding to the integrase catalytic core domain dimerization interface, and, as
a consequence, impart aberrant, multi-chain integrase polymerization that inhibits integrase binding to RNA
in virus particles and the morphological transformation of non-infectious immature viruses to infectious
mature virions. The most recent iteration of this grant described pirmitegravir, the first ALLINI to advance to
phase II clinical trials, and solved high resolution 3d structures of ALLINIs bound to the complete integrase
binding interface that includes the integrase C-terminal domain in addition to the catalytic core domain dimer.
Although HIV-1 integration occurs in human chromatin, the precise nature of LEDGF/p75 chromatin binding
activity in HIV-1 integration targeting is unknown and will be determined in this R37 extension application.
Prior to integration, virus capsid-host factor interactions enable HIV-1 nuclear incursion, but pathways taken
downstream from capsid-host factor engagement to LEDGF/p75-dependent integration are also unknown
and will accordingly be determined herein. Finally, to emulate our ALLINI discoveries and to define new
integrase interfaces for pharmacological development, we will characterize and determine 3d structures of
novel host factor-integrase complexes.
RELEVANCE (See instructions):
Continual antiviral inhibitor development is important to keep the HIV/AIDS pandemic in check, and we
previously described allosteric integrase inhibitors that compete for LEDGF/p75-integrase binding.
LEDGF/p75 directs integration into active genes, and this grant will elucidate molecular details of LEDGF/p75
action in HIV-1 integration. We will also characterize novel integrase-host factor complexes to define new
targets for future drug development.

Public health relevance
PROJECT NARRATIVE Allosteric integrase inhibitors are a promising class of antiretroviral drug compounds. Herein we will elucidate the mechanism of allosteric integrase inhibitor drug action in part focusing on the host cell factor LEDGF, and characterize new complexes between integrase and host factors with the goal to define new targets for future drug development.